Essential functions of OGT in host defense mechanism

Project Summary
Cellular metabolism instructs immune cell functions in both physiological and disease conditions. Activation of
immune cells in response to invading pathogens induces a robust metabolic reprogramming, which has been
indicated to play a critical role in orchestrating immune cell functions. The possibility of modulating immune
cell function through metabolic regulation represents a new strategy to strengthen host defense mechanism.
However, the role of individual metabolic pathways and enzymes during pathogen infection is not well
understood, which represents a critical knowledge gap. Recently, we have identified the O-GlcNAc transferase
(OGT), an important glucose metabolism enzyme, as a critical regulator of innate immune signaling during
virus infection and septic inflammation. OGT mediates a ubiquitous post-translational modification (PTM) of
cytosolic and nuclear proteins, known as O-GlcNAcylation. OGT-mediated O-GlcNAc signaling is well known
as an essential regulator of many fundamental aspects of cell physiology and dysregulated O-GlcNAc signaling
occurs in numerous human diseases. Despite a broad pathophysiological significance of OGT, the function of
OGT in host defense mechanism against pathogen infection is just emerging and still underappreciated. Our
preliminary results indicate that OGT directly restricts intracellular replication of both virus and bacteria, in
addition to its previously established impacts on regulating innate immune signaling. By studying cell and
mouse models with either OGT gene-deletion (Ogt-KO) or enzyme-inactive OGT (OgtK908A), we observed both
enzyme-dependent and -independent functions of OGT in modulating innate immune signaling and limiting
intracellular pathogen replication. We hypothesize that OGT serves as a central component of host
defense mechanism by sensing pathogen infection and integrating innate immune signaling and
cellular lipid metabolism via both enzyme activity-dependent and -independent manner.
The long-term objective of our work is to determine the principles, functions and mechanisms of OGT
and O-GlcNAc signaling in health and diseases. In this proposal, we aim to use our newly developed OGT
enzyme-inactive mouse model and OGT gene-deletion model to understand the molecular mechanism by
which OGT mediates host defense responses against invading virus and bacteria. We will advance this goal
through three directions: 1) how does OGT sense virus infection and integrate innate immune response and
cellular fatty acid synthesis pathway? 2) what is the functional importance of OGT-mediated protein O-
GlcNAcylation in the detection of intracellular bacteria? and 3) how does the ubiquitination of OGT affect host
defense? This study will significantly advance the field of immunometabolism by elucidating the function and
mechanism of an important metabolic enzyme sensing and antagonizing pathogen infection. Successful
development of OGT enzyme-inactive mouse model will also benefit other research topics such as cancer,
diabetes and neurodegenerative diseases.

Public health relevance
Project Narrative Dramatic changes in glucose metabolism-associated O-GlcNAc signaling occur in response to pathogen infection. Based on my preliminary results, I aim to study the role and mechanism of the O-GlcNAc transferase in mounting host defense response against viral and bacterial challenge. Dissecting the enzyme activity- dependent and -independent function of OGT in host defense mechanism will be instrumental for the generation of new strategies targeting the prevention and/or treatment of infectious diseases.